Regulation of antibiotic tolerance in Mycobacterium abscessus by proteolytic signaling

ABSTRACT:
Nontuberculous mycobacteria (NTM) infections such as Mycobacterium abscessus (Mabs) are a
growing health concern, particularly in older and immunocompromised patient populations, and
are among the most difficult bacterial infections to eradicate. Thus, there remains a critical need
to understand the mechanisms enabling Mabs to survive prolonged exposure to lethal antibiotics.
The central hypothesis of this proposal is that antibiotic tolerance is a regulated process,
controlled by pathways that sense discrete stresses, and transduce signals leading to a
coordinated cellular response that mitigates antibiotic cytotoxicity. In our preliminary data we
present the results of a Tn-Seq screen to identify genes contributing to antibiotic tolerance. We
now propose to use cutting-edge proteomics to study several proteases that were identified in the
Tn-Seq screen.

Public health relevance
NARRATIVE If successful, these studies would provide insights that could be leveraged therapeutically to develop “persistence inhibitors” that act cooperatively with traditional antibiotics to hasten Mabs eradication in patients.